Therapeutic Targeting of Monoacylglycerol Lipase After Traumatic Brain Injury

PROJECT SUMMARY
Traumatic brain injury (TBI) is a major health concern in terms of human disability, medical expenses, and lost
productivity. In addition to immediate mechanical trauma, secondary neurovascular dysfunction, including
cerebral edema, impaired cerebral blood flow, and neuronal cell death, worsens patient outcome in the hours
and days after TBI. Acute activation of toll-like receptor 4 (TLR4) on myeloid cells aggravates inflammation and
edema after experimental TBI and correlates with poor outcomes after clinical TBI. Activation of myeloid TLR4
increases the polarization of naïve helper T cells (TH0) into pro-inflammatory TH1 and TH17 cells, for weeks
after TBI phenotypes. As TH1 and TH17 cells augment T-cell mediated immunity, amplify pro-inflammatory
macrophage/microglia activation, and perpetuate neurodegeneration, the identification of novel strategies to
reduce post-traumatic inflammation may substantially improve patient outcomes. Endocannabinoids, such as
anandamide (N-arachidonoylethanolamide, AEA) and 2-arachidonoylglycerol (2-AG), are arachidonate based
lipids that activate the cannabinoid receptors, CB1R and CB2R. CB2R activation restores immune balance,
reduces edema, improves vasculature function, and enhances behavioral outcomes, suggesting a protective
effect of endocannabinoids after TBI. Of note, activation of the endocannabinoid metabolizing enzyme
monoacylglycerol lipase (MAGL), which selectively degrades monoacylglycerols, such as 2-AG, into free fatty
acids and glycerol, worsens outcomes after brain injury. However, the role of MAGL remains poorly defined
after TBI. Our long-term goal is to define the regulatory mechanisms and functional implications of eCS after
TBI, which may establish a mechanistic framework to advance the development of immunomodulatory
therapeutics to enhance patient outcomes. Our central hypothesis is that the endocannabinoid metabolizing
enzyme, MAGL, is a molecular switch underlying pro-inflammatory activation after TBI. To test our hypothesis,
we propose three Specific Aims: Specific Aim 1 will test the hypothesis that myeloid-CB2R activation
improves neurovascular function via suppression of MAGL after TBI. Specific Aim 2 will test the hypothesis
that myeloid-specific TLR4 regulates MAGL in innate immune activation after TBI. Specific Aim 3 will test the
hypothesis that myeloid-specific deletion of MAGL limits myeloid-lymphoid interaction and thus, protects white
matter injury (WMI) and chronic behavioral deficits after TBI. Expected outcomes: Our proposed studies have
far-reaching translational implications, as demonstration of a key role for myeloid MAGL-CB2R-TLR4 in
regulation of inflammation and chronic WMI resolution may result in improved long-term TBI outcomes.

Public health relevance
PROJECT NARRATIVE Traumatic brain injury (TBI), a leading cause of mortality and long-term disability worldwide, is a significant public health issue, debilitating or killing more individuals that breast cancer, AIDS, multiple sclerosis, and spinal cord injury combined. In this project, we will implicate the modulation of MAGL-CB2R-TLR4 axis in myeloid cells in the attenuation of the secondary neurovascular injury after TBI. Our conceptually and technically innovative studies will establish a mechanistic framework for the development of novel therapeutic approaches and will identify a potential biomarker to prospectively identify patients at high risk for neurological deterioration.